Development and Testing of a Multi-Component Intervention to Support HIV Care Engagement among Patients Receiving Cancer Treatment in Zimbabwe

ABSTRACT
In Zimbabwe, the burden of cancer among people with HIV is increasing. Consistent engagement in HIV care
is critical to reducing morbidity and mortality among people with HIV in general, and continuation of ART
through cancer treatment is essential for people with HIV who have cancer. Because the cancer and HIV care
pathways in Zimbabwe are siloed, people with HIV who are attempting to access cancer treatment face unique
barriers to engagement in both care continua. While guidelines for treatment of people with HIV and cancer in
low- and middle-income settings recommend integration of cancer and HIV care, there is a limited evidence
base for how to accomplish this successfully in these settings. There is an important gap in provision of
continuous HIV care when people with HIV in Zimbabwe receive a concurrent diagnosis of cancer. The goal of
this project is to address that gap by identifying barriers to HIV care engagement specific to people
with HIV receiving cancer treatment, and devising, refining, and testing strategies to address those
barriers. In Aim 1, we will use questionnaires and routinely collected clinical data to measure disruptions to
HIV-related care over time among cancer patients with HIV. In Aim 2A, we will use a mixed-methods approach
including questionnaires and in-depth interviews to quantify and contextualize patient-identified barriers and
facilitators to consistent engagement in the HIV care continuum during cancer treatment. In Aim 2B, we will
first prioritize barriers based on ubiquity and strength of impact, then convene a group of experts and key
stakeholders in HIV and cancer healthcare and research to develop a set of strategies to address the highest
priority barriers. Strategies will be implemented and refined one at a time using a rapid cycle improvement
process, with a final set of 2-3 refined strategies combined and piloted together in Aim 3. In Aim 3, we will
measure the acceptability of the package of strategies to patients and hospital staff as our primary outcome.
Secondary outcomes will include uptake, experience of barriers and facilitators to HIV care engagement, and
disruptions to HIV and cancer care. We will compare secondary outcomes in Aim 3 participants to Aim 1
participants in a quasi-experimental pre-post study design. These aims constitute the mentored research
component of the candidate’s career development plan. In parallel with this research, the candidate will pursue
additional training in implementation science, qualitative methods, and the design and evaluation of clinical
care interventions, supported by an exemplary team of experienced HIV and cancer investigators in the United
States and Zimbabwe. The proposed work will address a critical gap in provision of clinical care for people with
HIV and cancer in Zimbabwe, and substantially expand Dr. Montaño’s methodological expertise, providing the
training, experience and data for her transition to independence.

Public health relevance
PROJECT NARRATIVE For people with HIV who have cancer, consistent engagement in HIV care is integral to successful cancer treatment, but the evidence base for integrating HIV care into cancer care in resource-constrained settings like Zimbabwe is limited. New strategies to support continuous engagement in HIV care during cancer treatment in tertiary care settings in Zimbabwe are needed. The proposed work addresses this critical gap by identifying barriers to HIV care engagement during cancer treatment, and developing, refining, and testing strategies to address those barriers.